Defining the neurodevelopmental role of the dNab2/ZC3H14 RNA binding protein

I. PROJECT SUMMARY The post-transcriptional regulation of RNA is crucial for establishing the gene expression profile of individual cells. Strict regulation of post-transcriptional events is important in neurons, as the spatial and temporal regulation of protein synthesis is critical for proper neural development. The addition of a poly(A) tail to the 3'- end of mRNA transcripts is a key post-transcriptional event that influences the export, stability, transport and translation of transcripts. Our lab has recently found that mutations in the ZC3H14 gene, which encodes an evolutionarily conserved zinc finger RNA-binding protein, cause an autosomal recessive non-syndromic form of intellectual disability. ZC3H14 binds polyadenosine RNA with high affinity in vitro and loss of ZC3H14 leads to extended poly(A) tails in a subset of RNAs. However, the function of ZC3H14 in neurons and the underlying brain dysfunction in intellectual disability patients is unknown. To address this gap in knowledge, we have developed a fly model of ZC3H14-associated intellectual disability by creating a null allele of the Drosophila melanogaster ortholog of ZC3H14, dNab2. In flies, loss of dNab2 causes extended poly(A) tails along with a number of neuronal-specific and neurodevelopmental phenotypes. Importantly, these neuronal defects can be rescued by expression of human ZC3H14, validating the use of the fly model to investigate the role of ZC3H14. The long-term goal of my studies is to understand how polyadenylation is regulated by ZC3H14 family RNA binding proteins in order to provide insights into the molecular defects that underlie brain dysfunction in ZC3H14-associated intellectual disability. Based on intriguing preliminary data, including genetic and physical links to the Drosophila counterpart of the Fragile X Mental Retardation protein (FMRP/dFMR1), we will test the hypothesis that dNab2 regulates a set of RNAs that are critical for proper neurodevelopment and function, a subset of which are also bound and co-regulated by dFMR1. This hypothesis will be tested though two complementary aims: 1) Identify specific RNA targets of dNab2 in neurons using an optimized Crosslinking RNA immunoprecipitation (RNA-CLIP) approach and examine how loss of dNab2 impacts these transcripts thus providing insight into the function of dNab2/ZC3H14, and 2) Further characterize an interaction that we have identified between dNab2 and dFMR1 in neurons to provide insight into how dNab2 and dFMR1 could coordinately modulate RNA targets. Successful completion of these aims will further our knowledge of ZC3H14-associated intellectual disability and may also provide invaluable insights into the pathology of the most common genetic cause of intellectual disability, Fragile-X Syndrome, through our analysis of the dNab2/dFMR1 interaction.

Public health relevance
PROJECT NARRATIVE This proposal seeks to understand the function of a protein that is altered in patients afflicted with intellectual disability, which was previously referred to as mental retardation. This protein regulates RNA messages that carry genetic information from the nucleus into the cytoplasm of cells and influences how the information in these messages is decoded. Our proposed studies will provide insight into how expression of RNA messages is regulated in cells and also help us learn what is wrong in the brains of patients suffering from this form of intellectual disability. __SpecificAimsTextDelimiter__ III. SPECIFIC AIMS: Intellectual disability refers to a collection of debilitating diseases that impair cognitive function and limit adaptive behavior. The most common form of intellectual disability is Fragile X Syndrome, which is caused by loss of function of the Fragile X Mental Retardation Protein, FMRP. However, many additional causes of intellectual disability exist and new inherited forms are being defined. We have recently found that mutations in the ZC3H14 gene are associated with a non-syndromic form of intellectual disability. ZC3H14 encodes an evolutionarily conserved zinc finger protein that binds to polyadenosine RNA with high affinity and is enriched in the axons of mouse hippocampal neurons. Although little is known about the function of ZC3H14, studies in model organisms provide insight into the function(s) that may be impaired in patients. In all organisms examined, ZC3H14 proteins bind to polyadenosine RNA and loss of the ZC3H14 family member protein leads to elongated poly(A) tails among a subset of total RNAs. Importantly, analysis of the ZC3H14 ortholog in Drosophila melanogaster, dNab2, has provided key insights into the function of this protein in neurons. Developmental phenotypes observed in dNab2 mutant flies are primarily due to loss of dNab2 in neurons. These phenotypes include reduced adult viability, impaired locomotor response, defective short-term memory, and inappropriate axon trajectories in the mushroom bodies, which are invertebrate brain structures required for learning and memory. Importantly, the molecular role of dNab2/ZC3H14 in neurons is unknown. My preliminary evidence suggests that dNab2 physically interacts with the fly FMRP homolog, dFMR1, in brain neurons. Furthermore, adult flies null for either dNab2 or dFMR1 show closely related mushroom body axon defects and impaired short-term memory phenotypes. These biochemical and genetic data suggest that dNab2 and dFMR1 may have overlapping functions or may function in the same pathway in the developing central nervous system. I hypothesize that dNab2 regulates a set of RNAs that are critical for proper neurodevelopment and function, a subset of which are also bound and/or co-regulated by dFMR1. The proposed studies will begin to define the normal neurodevelopmental role of ZC3H14/dNab2 but may also provide invaluable insights into the pathology of the most common genetic cause of intellectual disability, Fragile X Syndrome, through our analysis of the dNab2-dFMR1 interaction. I will address my long-term goal of understanding the molecular defects that underlie brain dysfunction in intellectual disability through the following complementary Specific Aims: Aim 1: Define neuronal targets of dNab2 and explore how these target transcripts are modulated Hypothesis: dNab2 associates with and regulates transcripts required for proper mushroom body development. Through a combination of RNA-Sequencing analysis and testing candidate genes for genetic interaction with alleles of dNab2, we have identified a series of likely dNab2-target RNAs that will be tested for association with dNab2 by a recently optimized, neuron-specific crosslinking-IP (CLIP) approach. These RNA-CLIP precipitates will also be analyzed by high-throughput sequencing to identify additional dNab2-bound RNAs. Target transcripts, beginning with a transcript already identified as being bound by dNab2 in brain neurons, Pde1c, will be analyzed for changes in steady-state RNA and protein levels as well as changes in poly(A) tail length upon loss of dNab2. Such experiments are aimed at identifying the molecular consequences of impaired dNab2 function. Significant attention will be focused on dNab2-associated RNAs that are documented dFMR1 targets. Aim 2: Characterize functional interactions between dNab2 and dFMR1 in neurons Hypothesis: dNab2 and dFMR1 interact to regulate a subset of transcripts critical for neuronal function. A number of phenotypes identified in dNab2 mutant flies parallel those described for dFMR1 mutant flies, which are a well-validated model of Fragile X Syndrome. These phenotypes include defects in memory and axon trajectories in the mushroom bodies. My preliminary data reveals that dNab2 and dFMR1 genetically interact and that dNab2 and dFMR1 can be co-immunoprecipitated from brain neurons, suggesting these two proteins may function in similar pathways or impact a subset of overlapping target RNAs. To begin to define the step in post-transcriptional processing where dNab2 and dFMR1 could cooperate, we will determine whether the proteins interact in the nucleus or the cytoplasm of neurons and whether the interaction is RNA- dependent. As we have evidence that both ZC3H14 and dNab2 can be detected within cytoplasmic foci in cultured primary neurons, we will next determine whether dNab2 and dFMR1 co-localize in cytoplasmic RNA granules that could regulate RNA trafficking or expression. Finally, we will employ a genetic approach to determine whether dNab2 and dFMR1 function in the same pathway by testing for functional interactions between dNab2 and dFMR1 alleles in the process of mushroom body development. Impact: These studies will exploit a validated Drosophila model to provide insight into the function of a conserved RNA binding protein, dNab2/ZC3H14, that has hallmarks of a critical regulator of RNA expression in neurons, including physical association with dFMR1, an associated intellectual disease, and a neurodevelopmental role in axon guidance and projection. We anticipate that insights gained from this Drosophila model will provide a framework to understand ZC3H14 function in humans.